Yale Diabetes Research Center

The Yale Diabetes Research Center (DRC) was established in 1993 with the goal of promoting research in
diabetes and related metabolic and endocrine disorders at the University. The DRC brings together a
multidisciplinary group of over 100 member and associate member scientists as well as professional supporting
staff, new investigators and research trainees from in many departments and 4 colleges or schools at Yale
University The scope of the research activities of the membership is very broad, ranging from basic molecular
and cellular biology to whole body physiology and the treatment of diabetic patients. DRC members, however,
share a common interest in research focused on diabetes or related metabolic disorders or that is fundamental
to the understanding of its pathogenesis or for the development of new diabetes treatment strategies. The design
of the Yale DRC is aimed at developing an infrastructure that could serve as a catalyst to achieve these goals.
The cornerstone of the DRC is its five Research Cores that provide funded basic and clinical investigators with
the opportunity to more efficiently utilize resources and expand the scope of their research programs. The Clinical
Metabolism and the Diabetes Translational Cores facilitate metabolic research in patients, whereas the
Molecular Genetic Mouse Core, Physiology and Cell Biology Cores that comprise the more basic science focus
of the Center offer investigators the tools to create and test novel animal models starting from the molecule and
ending with biological outcomes. The Administrative Core oversees the operation of the Center, its
Pilot/Feasibility Project and Enrichment Programs, and helps to coordinate patient-based research in diabetes.
The goals of the DRC are to: 1) stimulate multidisciplinary interactions, particularly between basic and clinical
scientists; 2) encourage established investigators not presently working in diabetes-related areas, to bring their
expertise to bear on problems relevant to diabetes; 3) efficiently organize tim e consuming and/or costly
techniques through Core facilities to enhance the productivity of investigators conducting research in diabetes
related areas; 4) promote new research programs through pilot feasibility projects; 5) enhance the quality of
diabetes research training, and 6) create a stimulating institutional environment that expands research efforts of
its members to achieve new strategies to prevent and treat diabetes at the local, and ultimately at the national
level.

Public health relevance
The Yale Diabetes Research Center provides the scientific infrastructure to support a wide spectrum of clinical and basic scientists who are working to better understand the factors driving the development of diabetes and to facilitate the translation of discoveries from the bench to the bedside that lead to new strategies for the treatment of individuals with, or who are at risk for developing diabetes.